The Impact of Weight Loss on Alzheimer's Disease Risk in Adults with Down Syndrome

Abstract
The prevalence of Down syndrome (DS) or trisomy 21, the most common chromosomal abnormality
associated with intellectual disability (ID) has increased from ~50,000 in 1950 to ~250,000 in 2017. Most adults
with DS will develop pathology associated with Alzheimer's disease (AD) beginning at ~ 30 years of age. By
age 65, the cumulative incidence of dementia exceeds 90% and is the leading cause of death in individuals
with DS. High prevalence of obesity (~81%) and the accompanying chronic oxidative stress may be associated
with increased risk for AD in adults with DS. The available data from trials in typically developed adults
suggests the potential for weight loss achieved through a reduced energy diet and/or consuming a low
glycemic load, low saturated fat, high fruit and vegetable (F/V) diet to prevent or delay the development of AD.
However, the potential of dietary interventions to prevent or delay AD in adults with DS has not been previously
examined. Our group has developed a multi-component intervention which includes a reduced energy
enhanced Stop Light Diet (eSLD), individual behavioral counseling/education, and daily self-monitoring that
has been shown to achieve clinically relevant weight loss (≥ 5%) and improved diet quality in adults with ID.
The eSLD includes daily consumption of 2 portion-controlled entrées (~200 kcal each), 2 low-calorie/high
protein shakes (~100 kcal each), a minimum of 5 servings of F/V, and ad-libitum non-caloric beverages.
Participants are asked to select additional low energy food, if desired, using the SLD system: green (low
energy), yellow (moderate energy), and red (high energy). Results from 2 completed (pilot + DK83539) and 1
on-going trial by our group (DK114121), including 335 adults with ID (78 with DS), have demonstrated
improved diet quality and clinically relevant weight loss at both 6 mos. (-6.2%) and 12 mos. (-6.8%) using our
multi-component intervention with the eSLD. The proposed 2 phase project (clinical readiness and randomized
pilot trial) will evaluate the impact of weight loss and diet intake on factors that may prevent or delay the
development of AD in adults with DS including biomarkers, cognitive function, cerebral antioxidants, and brain
volume. During the clinical readiness phase, we will complete 10 milestones to prepare for successful
administration of the RCT. During the RCT phase, adults with DS and overweight/obesity without dementia
(n=81) will be randomized (2:1) to a 12-month multicomponent weight management intervention using a
reduced energy eSLD + specific recommendations from the Mediterranean-DASH Intervention for
Neurodegenerative Delay (MIND) diet or a health education control. We will calculate effect sizes for changes
in biomarkers related to AD, cerebral antioxidants and brain volume, and cognitive function in both intervention
arms across 12 mos. Additionally, we will assess the independent association of weight loss and changes in
dietary intake with changes biomarkers related to AD, cerebral antioxidants and brain volume, and cognitive
function

Public health relevance
Project Narrative Strategies for promoting healthy brain aging and preventing/delaying Alzheimer's disease are needed in adults with Down Syndrome (DS), a population at high risk of developing Alzheimer’s disease. The promotion of weight loss and improvements in diet quality in adults with DS may improve cognitive function and prevent or delay Alzheimer’s disease.